State of Oklahoma plan for conformance with Manufacturing Regulatory Program Standards

MANUFACTURED FOOD REGULATORY PROGRAM STANDARDS
OKLAHOMA STATE DEPARTMENT OF HEALTH
PROJECT SUMMARY/ABSTRACT
This grant opportunity would allow the Oklahoma State Department of Health (OSDH) to assess the
manufacturing food program in relation to the Manufactured Food Regulatory Program Standards
(MFRPS), identify any gaps in the program, and create a plan to address those disparities.
Oklahoma’s compliance with the MFRPS standards would assist with creating a nationally integrated
food safety system that is in line with the other 43 states that are currently enrolled in the MFRPS.
Additionally, this project will ensure consistency within our state program, ensure our staff are properly
trained, and provide mechanisms, standard operating procedures, and resources to protect the health of
the residents in Oklahoma. Enrollment in these standards and this funding opportunity helps OSDH
provide safe food to consumers which is one step closer to OSDH’s mission of creating a “State of
Health”.
A self-assessment performed in the first year of the project will identify any gaps in our manufacturing
program. Gaps identified will be prioritized by staff, and then set for project management and review.
The agencies specific aims are to gain at least partial conformance with all standards. Initial priorities will
be creation of Standard Operating Procedures and Training Plans. OSDH has a long-term goal of full
conformance with as many standards as possible. Progress will be measured with self-assessments at
the end of each award period.

Public health relevance
MANUFACTURED FOOD REGULATORY PROGRAM STANDARDS OKLAHOMA STATE DEPARTMENT OF HEALTH PROJECT NARRATIVE This project supports public health by creating a national integrated food safety system with other states enrolled in the Manufactured Food Regulatory Program Standards. A standardized inspection program with written standard operating procedures, quality assurance checks, risk-based inspections, and proper training is important to ensure manufactured food is produced safely in the State of Oklahoma. These standards are science-based, comprehensive, and provide another layer of assurance that Oklahoma State Department of Health inspectors can protect the health of the Oklahoma consumer.